Testing the Pain Relief of musculOskeletal conditions and Arthritis using Culturally Tailored InterVentions for Black Elders (PROACTIVE) Intervention: A Randomized Controlled Trial

PROJECT SUMMARY/ABSTRACT
Chronic musculoskeletal conditions and their primary source of pain, movement-evoked pain (MEP), causes
significant pain interference, long-term mobility impairment, healthcare costs, and psychosocial inequalities for
individuals, families, communities, and society-at-large. MEP affects more Black/African Americans (B/AAs) and
is perceived as more severe. Compounded by race, age, and more disadvantageous social determinants of
health (SDoH), this unequal burden of pain becomes even greater in health disparity populations, such as older
B/AAs. Many B/AA older adults hesitate to use opioids and non-steroidal anti-inflammatory drugs long-term and
rely on non-pharmacological pain self-management (SM) strategies. Current chronic musculoskeletal pain
(CMP) SM interventions do not measure MEP as a primary endpoint nor address faith/spirituality, Black culture,
and underlying potentially modifiable SDoH (e.g., health literacy, financial hardship), and therefore only offer
small or no benefit over control groups. We propose to enhance older B/AAs’ capacity to manage MEP by
investigating the effects of a socioculturally congruent pain SM intervention (Pain Relief for musculOskeletal
conditions and Arthritis using Culturally-Tailored InterVentions for Black Elders [PROACTIVE]). This prototype
intervention will provide culturally congruent pain SM education with a SM resource toolkit, active prayer, and
financial counseling to explain participants’ healthcare benefits for pain care. This intervention moves beyond
basic cultural tailoring and targets multiple areas for behavior change that are of importance to older B/AAs. We
have assembled a demographically diverse, interdisciplinary, and clinically experienced team to lead this study.
We will enroll 120 B/AAs (50 years and older) with CMP into a parallel group, single-blind, randomized controlled
trial to test whether PROACTIVE decreases MEP in the immediate post-intervention period (n= 60) (Aim 1) and
over time (Sub-Aim 1a) compared to a usual care control group (n= 60). To determine efficacy, we will use state-
of-the-art and real-time technologies to measure primary outcome as well as pain interference, pain coping, and
physical function (secondary outcomes) (Sub-Aim 1b). The PROACTIVE group will work with a faith-community
nurse and financial counselor over four weeks to enhance knowledge of CMP SM, utilization of active prayer
and faith, and financial literacy of health insurance benefits and resources available to cover treatments for pain.
Each weekly session will last up to 2 hours and will be followed by six days of ecological momentary assessments
of pain and SM outcomes and ecological momentary interventions guiding participants through weekly SM
practice skills. A fourth booster session will reinforce content and training and help sustain SM. Also, we will
examine the differential effects of PROACTIVE on MEP according to demographic (sex as a biological variable,
gender, age), psychosocial, and SDoH factors (Aim 2). The proposed intervention is expected to produce
meaningful reductions in MEP in B/AA older adults experiencing disabling chronic musculoskeletal conditions.
Ideally, this study will identify precision behavior targets and responders to inform intervention refinement.

Public health relevance
PROJECT NARRATIVE Chronic musculoskeletal pain, while a leading cause of disablement, is a neglected national health disparity issue in Black communities; as a matter of fact, only 11% (median) of participants in NIH-sponsored chronic pain research were identified as Black/African American. Specifically, chronic musculoskeletal pain is primarily driven by movement-evoked pain which contributes to pronounced mobility limitations and disability in Black/African American older adults. Disrupting persistent patterns of disparity in this population demands novel culturally congruent self-management interventions that will advance health equity and attenuate the adverse economic, functional, and mental health consequences associated with chronic musculoskeletal pain.